The Center for Innovation in Child Maltreatment Policy Research and Training (CICM) Community Engagement Core (CEC)

CICM Community Engagement Core Abstract
The Center for Innovation in Child Maltreatment Policy, Research, and Training (CICM) Community
Engagement Core (CEC) is informed by the activities and expertise of the Administrative Core (AC) Steering
Committee Learning Collaborative (SCLC) and research projects. The Community Engagement Core (CEC) is
integrally tied to the AC. CEC activities include education and training of the future generation of practitioners
and researchers across disciplines, engaging the community in the process of advising and prioritizing CICM
research, and translation of knowledge into tailored dissemination products that support the activities of
existing practice and policy stakeholders. The CEC training and dissemination approach guiding principles
include: A) transdisciplinarity, B) community participation, C) attention to culture and context, and D) evidence-
based workforce development. The AIMS of the CEC are to: (1) Engage research, policy and practice
stakeholders in translation of research into policy and practice as well as identification of real world policy and
practice issues that require research. National, state and regional partners are not just recipients of
dissemination products but actively engaged in research prioritization and generation. To maximize
participation, CEC integrates concepts from community based participatory research (CBPR), including
curricula (Community Research Fellows Training) adapted by a CICM faculty to support the research literacy of
agency and advisory board members to assure effective communication; and to (2) Provide innovative
education and training opportunities to build a pipeline of researchers and practitioners prepared to address
the complex issue of child maltreatment. Pre-doctoral, doctoral and postdoctoral students across public health,
public policy, social work, medicine and computer science are integrated into the generation and translation
activities of both cores, benefiting from experts from multiple disciplines. CEC activities are designed produce a
culturally competent and contextually aware workforce in practice and research settings creating innovative
programs like the CICM Indian Child Welfare Specialist training initiative and tailored evidence dissemination
approaches to address the needs of clinical, administrative and policy contexts. The CEC is Co-Directed by Dr.
Weaver, a Saint Louis Univ. faculty expert in behavioral and health communication and injury prevention; and,
Dr. Patterson Silver Wolf, a Washington Univ. faculty expert on underrepresented minority (American
Indian/Alaska Native) health and wellness, college success among underrepresented minority students,
addictions, and adoption of evidence-based practices. Both serve on the SCLC to enhance core coordination
and meet with the CICM PI, Dr. Jonson-Reid, monthly. They are supported by the CICM coordinator, a team of
investigators and consultants from medicine, psychology, and public policy, and funded graduate and doctoral
research assistants.